Nanopore Enabled Exonuclease Sequencing

Project Summary The overall goal of this program is to develop a nanopore that will allow DNA mononucleotides, such as those released from an exonuclease, to be captured and read with 100% accuracy, thus enabling the exonuclease/nanopore-based sequencing concept. While base discrimination with a molecular adapter has been previously demonstrated, capturing the molecules with 100% efficiency is the current limitation. By creating the proposed device, we will be able to use novel methods to control the molecular transport rate of the mononucleotides to and through the pore, enabling 100% capture efficiency.

Public health relevance
Project Narrative The proposed program will address critical factors currently preventing nanopore sequencing from realizing its full potential. The success of this program will thus help enable rapid and inexpensive DNA sequencing, which will greatly increase access to full genome sequencing. Such routine DNA sequencing will enable significant improvements for human health including the use for personalized medicine, detecting and understanding genetic mutations and diseases as well as the use with pathogen detection.